EFFECT OF 17 BETA-ESTRADIOL ON CORONARY VASCULAR HEMODYNAMICS IN POSTMENOPAUSE

We have recently found that 17 beta-estradiol acutely improves forearm endothelium-dependent vasodilation in postmenopausal women. To determine if estrogen enhances coronary endothelium-dependent vasodilation, we studied 16 postmenopausal women, average age 61 years, 13 of whom had no significant coronary artery disease. Infusion of acetylcholine into the left main coronary artery was used to test endothelium-dependent function and infusion of adenosine was used to test endothelium-independent function. Blood flow was derived from Doppler flow velocity and coronary diameter measurements. Acetylcholine and adenosine were re-infused after 15 minutes of intracoronary 17 beta-estradiol at 75 ng/min. Coronary sinus estradiol levels increased from 17+/-12 to 272+/-122 pg/ml. Estradiol did not affect basal coronary flow or vascular resistance. The infusion of estradiol resulted in a 50% potentiation in the vasodilator response to acetylcholine but had no impact on adenosine-induced vasodilation. Thus, 17 beta-estradiol acutely and selectively potentiates endothelium-dependent vasodilation in the coronary vasculature of postmenopausal women, an effect which may contribute to the reduction in coronary events observed with estrogen replacement therapy.